Experimental & Analytical Core

The LSUHSC Comprehensive Alcohol-HIV/AIDS Research Center (CARC) Experimental & Analytical Core uses
a unified and integrated approach to support studies proposed by all research components (RCs), pilot projects,
and other studies supported by CARC. The Core will facilitate bidirectional translational cross-sectional and
longitudinal investigations using the established longitudinal cohort of more than 400 people with HIV (PWH)
and HIV seronegative participants enrolled in the New Orleans Alcohol Use in HIV (NOAH) Study, complemented
with the most relevant preclinical model of HIV infection - the simian immunodeficiency virus (SIV)-infected nonhuman primate (NHP), and state-of-the-art analytical facilitites to address the impact of alcohol use on
comorbidities among PWH. For this funding cycle, the Core will support conducting a pharmacological
intervention in NHP and will facilitate the delivery of a cognitive behavioral intervention to PWH enrolled in NOAH.
These interventions will explore their effectiveness in ameliorating alcohol associated comorbidities and provide
insight into pathological mechanisms affected by alcohol use. Major strengths of this Core include established
and quality controlled clinical and NHP experimental protocols, analytical tools, sophisticated instrumentation,
and the potential to develop and implement novel assays to test hypotheses.

Public health relevance
LSUHSC CARC Research Component 1 (RC1) Research Component 1 (RC1) of the Louisiana State University Health Sciences Center (LSUHSC) New Orleans Comprehensive Alcohol-HIV/AIDS Research Center (CARC) will examine the impact of environmental and psychosocial stress on the intersections of HIV related The Experimental & Analytical Core provides a unified and integrated approach to support research of the LSUHSC Comprehensive HIV/AIDS Alcohol Research Center (CARC). The Core will facilitate bidirectional translational cross-sectional and longitudinal investigations to maximize research resources and promote synergy among the CARC investigators. The Core concentrates expertise, experience, and resources guaranteeing valid and uniform processes, scientific rigor and integrity, avoidance of bias, and adherence to regulatory guidelines.